NBER Center for Aging and Health Research-Post COVID-19 Experiences Among Adults with ADRD

OTHER PROJECT INFORMATION – Project Summary/Abstract
Post COVID-19 Experiences Among Adults with ADRD: Individual, Provider and Community
Characteristics Associated with Improved Health Outcomes
COVID-19 has disproportionately impacted older individuals with Alzheimer’s Disease and Related Dementias
(ADRD), for whom COVID-19 mortality rate was twice as that of older patients without ADRD. Even among
survivors, COVID-19 may have further amplified the short-, medium- and long- term morbidity among ADRD
patients. The rationale of the proposed research is that a better understanding of how COVID-19 infections and
severity of infection has shifted future trajectories of healthcare utilization among ADRD patients will enable
designing more effective interventions for older adults with ADRD whose care needs and quality of life may have
been altered post-COVID-19 infection. This research will be essential for informing optimal policy responses
(now and in the future) and will align with the NIH NIA’s goal to characterize measures or short and medium- -
term post-COVID-19 healthcare use among fee-for-service Medicare and Medicare Advantage enrollees with
prevalent ADRD. We hypothesize that among those with diagnosed COVID-19, people with ADRD will exhibit
more severe effects even after adjusting for standard factors, and that these effects will differ by intensity of
COVID disease. In addition to ADRD diagnoses, we will construct diagnoses measures of different aging-related
brain syndromes (Mild Cognitive Impairment, delirium, etc.), as well as baseline frailty and comorbidity for each
patient. We will follow them through a COVID-19 diagnosis or hospitalization, a successful discharge (if
hospitalized), and subsequent mortality (in and out of hospital), post-ICU readmission, and other relevant health
care use measurable in claims data.
Our second specific aim will identify individual sociodemographic, clinical, setting-of-care and geographical
factors associated with improved recovery post-COVID19 among patients with ADRD.
This research will advance the goals of the parent grant, NBER Center for Aging and Health Research by
expanding our understanding of the challenges associated with the compounding impact of the COVID-19
pandemic on delivery of care for patients with ADRD, in preparation for an R01 to continue to study long term
outcomes. Understanding the factors associated with improved long-term outcomes of people experiencing
COVID-19 will help local, state and national policy makers design strategies to tailor for the needs of rapidly
growing population of ADRD and at-risk of ADRD patients and for distribution of resources for this vulnerable
group of citizens.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative Our research will examine the nature and disparities of Long-COVID-19 symptoms among patients with ADRD who have experienced but survived COVID-19 diagnoses and hospitalizations. Understanding the factors associated with improved long-term outcomes of ADRD patients experiencing COVID-19 will help local, state and national policy makers design strategies to tailor for the needs of rapidly growing population with ADRD or at-risk of ADRD patients and for distribution of resources for this vulnerable group of citizens.